HUMAN LABORATORY ASSESSMENT OF THE SAFETY AND POTENTIAL EFFICACY OF VARENICLINE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To determine the safety and tolerability of treatment with varenicline in MA-dependent volunteers.